Life history of the menstruating uterus

PROJECT SUMMARY
The uterus has the unique ability to support the growth, development, and eventual delivery of offspring. The
non-pregnant uterus is no less remarkable: the uterine lining (endometrium) undergoes repeated cycles of
shedding during menstruation and subsequent repair, ultimately regenerating approximately 400 times over the
reproductive lifespan. This repeated, scarless regenerative process holds immense potential for the identification
of new strategies to replace old or damaged tissues, which is a major goal for regenerative medicine. Moreover,
understanding endometrial regeneration has important clinical implications, as excessive or insufficient
endometrial regeneration gives rise to pathologies that affect the lives of hundreds of millions of women, non-
binary people, and transgender men around the world. It is critical to address the longstanding unmet needs of
people with endometriosis, adenomyosis, infertility, and to combat the rising incidence of endometrial cancers.
The goal of this project is to identify the molecular and cellular basis for regeneration of the menstruating
endometrium. A major challenge for the field is that humans belong to a very small group of mammals that
menstruate. Thus, although animal models propel many scientific studies, common animal models such as mice
and rats have limited utility for studies of menstruation. This project uses the common spiny mouse, which is the
only known menstruating rodent, to perform functional tests of the requirements for menstruation. In parallel, we
will develop approaches to determine how the human endometrium changes over time. Using these approaches,
we aim to understand how the endometrium changes when menstruation begins during puberty and restarts
after pregnancy. The proposed studies are an ideal fit for the New Innovator program because our understanding
of the menstruating endometrium has lagged far behind more commonly studied regenerative organs. Thus, we
must take strategic risks to propel us towards more precise mechanistic understanding of menstruation, a
fascinating process that affects the lives of large proportions of the population.

Public health relevance
PROJECT NARRATIVE The goal of this work is to understand how the human uterine lining (endometrium) repairs itself each month after menstruation. Understanding how this system regenerates can provide critical insights to improve stem- cell based therapies for regenerative medicine and allow us to develop new treatments for disorders including endometrial cancers, endometriosis, and uterine-factor infertility.